Developing in situ transcriptomics of a bioprinted follicular skin model

PROJECT SUMMARY / ABSTRACT
The goal of this proposal is to develop a platform to model host-microbe interactions in skin, featuring a 3D
bioprinted follicular skin model and spatial transcriptomics of host and microbial cells to retain physiologically
relevant interactions. In human skin, a majority of microbial interactions with the host epithelium and cutaneous
immunity is thought to occur in deeper, protective adnexal structures, e.g., hair follicles and glands. For
example, recent work in mice has suggested a homeostatic interaction between different tissue resident cells,
sebaceous glands, and the microbiome. Given the substantial diversity of the microbiome – encompassing
hundreds of different bacterial and fungal species, it would be highly impactful to model such potential
interactions systematically. In addition, examining interactions with human cells would best provide
translational data on cellular response to microbial colonization. However, there are major limitations in the 3D
skin models that are available – they lack complex structures where skin microbes reside, and second, current
approaches to investigate host-microbiome interactions lack resolution on spatial activity. Here, our two aims
address these key limitations. In Aim 1, we will develop a 3D bioprinted skin tissue model containing follicular
structures. In Aim 2, we will develop in situ microbial sequencing technology for spatial profiling of microbial
colonization of these tissues and other available human 3D skin models. These aims taken together will allow
us to address fundamental questions on the underlying biology of the skin microbiome, which we will pilot in
this R21. Our success would result in two new technologies that would enable construction of a high-resolution
spatial map of the microbiome and host interactions, enabling foundational investigations into mechanisms of
interstrain interactions and regulation of virulence to promote skin homeostasis.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH The numerous bacteria, fungi, and viruses that inhabit our skin play key roles in skin health, but we have a poor understanding of how these microbes actually interact with skin cells. To enable detailed investigation of microbe–skin cell interactions and their effects on skin health, we seek to develop two new technologies: 1) bioprinted, cultured skin tissue, which can be experimentally treated with defined species of microbes; and 2) a method to spatially map interactions between microbes and cells in the skin by exploiting the unique genes they express. These technologies will enable biomedical researchers to determine how microbe–skin cell interactions impact skin barrier functions, immunity, and susceptibility to diseases arising from microbial infection.